Colon O-glycosylated mucus in the homeostasis of microbiota and host

Over the past 15 years, our studies have established O-glycans as crucial components of the colonic mucus
barrier. Our recent publication demonstrates that the colon mucus is mainly formed from secretion of O-glycosylated
Muc2 by goblet cells (GCs) in the proximal colon, where it encapsulates the fecal materials including the microbiota.
These findings represent a paradigm shift from the current model of the colon mucus system and provide new insights
into host and microbiota symbiosis. However, whether the proximal colon contains a distinct subset of goblet cells
(pGCs), and the significance of proximal colon-derived mucus in inflammatory bowel disease is unstudied.
To address these questions, in our preliminary studies, we created a new surgical model in mice named cecal-
distal colonic anastomosis (CDA) with removal of the proximal colon. Our preliminary data showed CDA mice exhibited
impaired mucus layer and developed spontaneous albeit modest inflammation in the distal colon, highlighting the
physiological importance of the pGC-derived mucus for whole colon homeostasis. In parallel, we have adopted study
of the neo-colon mucosa created by ileal pouch-anal anastomosis (IPAA) in ulcerative colitis patients and its
intermittent acquisition of inflammation (pouchitis) as a human “cellular observatory”. Our preliminary data
demonstrated the feasibility of mucus characterization, single cell molecular methods, and cohort genetic variation
analytic methods in this model, to determine cell biologic and genetic contributions to gut homeostasis.
Built on these preliminary data and the importance of the proximal colon-derived mucus we recently discovered,
we hypothesize that loss of pGC diversity and plasticity contribute to defective colon homeostasis and inflammation.
We propose two Aims to test the hypothesis: Aim 1 is to determine how proximal colon-derived mucus governs the
colonic mucus barrier function. We will determine the unique cellular and molecular identity of the pGCs through single-
cell RNA sequencing, MERFISH spatial transcriptomics, glycomics, and functional analysis. We’ll also use the CDA
model to determine how lack of pGCs affects colon mucus function and the plasticity of the GCs in the distal colon.
Aim 2 is to identify human genes involved in GC programming and mucus production and their relation to inflammatory
bowel disease phenotypes. The ileal neo-colon created by IPAA in at-risk patients offers a temporal cellular
observatory of the initially unaffected ileal neo-colon, as adaption of mucosal GCs heterogeneity and plasticity ensues
with perturbations of inflammation and altered microbiome community states. We will conduct biopsy-based single-cell
RNA and chromatin analysis of GCs populations in the pouch mucosa as it adapts to inflammatory and microbiome
changes. We will also test for gene variants affecting this adaption by IPAA cohort genomic association analysis.
Successful completion of the project will 1) establish that pGCs are a unique subset of mucus secretion cells;
2) demonstrate the importance of proximal colon-derived mucus in maintaining homeostasis between microbiota and
host mucosa; and 3) provide new insights into the pathogenesis of inflammatory bowel disease such as pouchitis,
which may lead to new diagnostic and/or therapeutic options.

Public health relevance
PROJECT NARRATIVE Approximately 15% of patients with ulcerative colitis (UC) develop medically refractory disease or colorectal neoplasia requiring special surgery called IPAA to remove the diseased large intestine and to restore partial bowel function. An inflammatory disease, termed pouchitis, is a common and inadequately treated complication of IPAA. The proposed project is poised to provide novel insights into the role of intestinal mucin-type O-glycans in intestinal mucus barrier function and in pathogenesis of the common human disease, which may lead to a novel therapy for patients with UC.